Anatomical and gene expression resource for Macrostomum lignano

The Macrostomum lignano (Mlig) postembryonic anatomical atlas is a collaborative team effort. Dr. Matthew Voas has optimized cell dissociation, vital nuclear dye staining, and fluorescence activated cell sorting protocols required for sample preparation, and he is producing pilot 10x scRNA-Seq data sets in conjunction with Dr. Sevilay Turan and Dr. Bao Tran's team at the CCR Sequencing Facility at the NCI-Frederick Advanced Technology Research Facility. Postdoctoral Scientist Dr. Xintao Fan has determined the developmental time points, from hatchling to sexually mature adult, that are most biologically impactful for sequencing, and he determined the irradiation treatment regimen necessary for complete elimination of adult pluripotent stem cells and germ cells. University of Oregon Masters intern Laura Paez Baena developed a scRNA-Seq analysis pipeline tailored to Mlig expression data. Laura was the lead bioinformatic analyst for the project but her May 2023 departure means we are now working out new collaborative agreements with NCI Statistical Services staff for our analysis needs. Data sets have been acquired and we are moving on to analysis of our data. In We will work to create an interactive Shiny app that integrates digital and spatial gene expression data for differentially expressed genes defining anatomical entities captured in our analysis.